CONSTANT GROWTH HORMONE RELEASING PEPTIDE INFUSION

Gender differences exist in the neuroendocrine control of GH secretion in the human that are presumptively estrogen dependent. We plan to study GH response to a constant GRP-2 infusion with and without estrogen treatment in older women. Ten women have been studied. The data are being analyzed.